C-terminal Peptide of Cardiac Troponin I for the Treatment of Diastolic Hear Failure

Project Title: C-terminal Peptide of Cardiac Troponin I for the Treatment of Diastolic Heart Failure
Project Summary
Myocardial contractility is essential for cardiac function. Troponin-mediated thin myofilament regulation
controls cardiac muscle contraction and relaxation. The troponin complex consists of three protein subunits: the
calcium receptor troponin C (TnC), the inhibitory subunit troponin I (TnI), and the tropomyosin-binding subunit
troponin T (TnT). Cardiac TnI plays a pivotal role in myofilament activation and deactivation, determining the
kinetics of cardiac muscle contraction and relaxation, and pumping efficiency of the heart. Our research project
focuses on a novel therapeutic peptide derived from the conserved C-terminal end mobile domain of cardiac TnI
(cTnI-C27) for its effect on enhancing myocardial relaxation and the underlying mechanisms. Biochemical,
genetic and physiological approaches and mouse models of diastolic cardiac dysfunction are employed to study
cTnI-C27 peptide to understand its selective enhancement of diastolic function of the heart. The ultimate goal is
to develop a targeted treatment for diastolic heart failure (HFpEF) that presently lacks an effective treatment.
Three Specific Aims are proposed in the research plan: Aim 1 is to characterize the mechanism for
exogenous cTnI-C27 peptide to modulate myofilament function as an activated state-specific myofilament Ca2+-
desensitizer. We shall determine the binding site of cTnI-C27 peptide on tropomyosin in thin filament and
characterize its effect on contractile kinetics and endogenous troponin regulation of myofibril actomyosin
ATPase in reconstituted myofilaments and skinned cardiac muscle. The results will determine how exogenous
cTnI-C27 peptide modulates cardiac muscle contractility, especially the enhanceing of Frank-Starling response
without increasing sarcomere length. Aim 2 is to study the delivery of cTnI-C27 peptide into cardiomyocytes for
functional effect. Heart-homing fusion peptide, AAV9 and inducible transgenic expression of cTnI-C27 peptide
will be studied in vivo and in ex vivo working hearts. Effects on cardiac muscle contractility and heart function
will be examined for therapeutic efficacy in normal and diastolic dysfunctional and fibrotic mouse hearts to
evaluate the therapeutic potential of cTnI-C27 peptide. Aim 3 is to determine the chronic effects of exogenous
cTnI-C27 peptide on cardiac function and remodeling. To develop the cTnI-C27 peptide for the treatment of
chronic heart failure, we need to understand the effects of chronic presence of cTnI-C27 peptide on cardiac
muscle. We shall examine the therapeutic and side-effects of chronic transgenic expression of cTnI-C27 peptide
in normal and failing mouse heart. In vivo and ex vivo cardiac function, tolerance to hemodynamic stresses, and
myocardial remodeling will be examined in young and aging mice to collect informative longitudinal data.
With combined expertise in myofilament protein structure-function relationships and cardiac physiology and
pathophysiology using multi-level experimental approaches, the study of a promising therapeutic peptide of
endogenous origin will lay mechanistic and methodologic groundwork for translating a novel myofilament
mechanism into a new treatment for diastolic heart failure.

Public health relevance
Project Title: C-terminal Peptide of Cardiac Troponin I for the Treatment of Diastolic Heart Failure Program Narrative Troponin I (TnI) regulates cardiac muscle relaxation and is a therapeutic target in diastolic heart failure that is a clinical condition lacking effective treatment. The C-terminal 27 amino acid peptide isolated from cardiac TnI forms a functional reagent that selectively enhances diastolic function of cardiac muscle. Our research project investigates this myofilament-based mechanism for translational development toward a targeted treatment of diastolic heart failure.